The contribution of adult child socio-economic status to parents' risk and outcomes of Alzheimer's disease and related dementias (ADRDs) in cross-national settings

Globally, nearly 10 million older adults are diagnosed with Alzheimer’s disease and related dementias (ADRDs)
each year. Given the current absence of effective pharmacological treatments, along with global disparities in
dementia care, there is an urgent need to identify population-level targets of ADRDs prevention and intervention,
including at the family and societal level. Much of the population-level ADRDs research focuses on the
contributions of one’s own socio-economic status (SES) to later life ADRDs risk. However, in many global
settings, the SES of adult children may be a critical driver of parents’ economic, informational, and behavioral
resources in late life. Nevertheless, very little research has evaluated the impact of adult child SES on parents’
ADRDs risk or outcomes of ADRDs. This is a surprisingly overlooked opportunity given prior literature suggesting
that adult child educational attainment may influence parents’ physical and mental health and mortality
outcomes, independent of parents’ own education. The objective of this proposed study is to rigorously
evaluate the potential for adult child SES to reduce parental ADRDs risk and improve outcomes among
older parents with ADRDs in global settings. We will additionally evaluate a comprehensive set of
economic and non-economic pathways that may underlie observed associations and identify subgroups
of older adults who may benefit most from improvements to their children’s education. We propose to
use population-level cohort data on over 156,000 adults representing 20 countries in North and Central America,
Asia, and Europe, and with similar measures of adult child education and rich data on candidate mediators and
multi-level modifiers. These global data will allow us to achieve excellent external validity not possible with single-
country studies, and we will use rigorous observational approaches for analyses of main effects and mediation.
To maximize internal validity, we will validate observational estimates with a quasi-experimental approach that
leverages changes to compulsory schooling laws as “natural experiments” to identify the causal effect of
increases to adult child education on parents’ longitudinal cognitive outcomes. We have gathered an
interdisciplinary team with deep expertise in these global aging cohort data and the application of rigorous
epidemiologic and econometric methods to population-level research on cognitive aging to carry out the following
Specific Aims: 1) Quantify the influence of adult child SES on older parents’ cognitive decline, risk of probable
dementia or cognitive impairment, and outcomes for older parents after dementia onset, 2) Evaluate economic
and non-economic mediators of observed associations between adult child SES and parents’ ADRDs risk and
outcomes, and 3) Identify within and cross-country heterogeneity in the association between adult child SES and
parents’ ADRD risk and outcomes. Our study makes use of the over 20 years of investment of the National
Institute on Aging in global aging cohort studies to evaluate largely unanswered questions regarding the influence
of adult child SES on parents’ ADRDs risk and outcomes.

Public health relevance
Project Narrative Substantial research evaluates the contribution of one’s personal socio-economic status (SES) on risk for Alzheimer’s disease and related dementias (ADRDs) and outcomes after the onset of ADRDs, although in many global settings, adult children may be their older parents’ most critical socio-economic resource. In this project, we will evaluate the impact of adult children’s education on parents’ cognitive decline, risk for dementia/cognitive impairment, and on longevity, physical functioning, and psychosocial outcomes for older parents after dementia/cognitive impairment onset using data on over 156,000 older adults from global aging cohort studies representing 20 countries in North and Central America, Asia, and Europe. We will additionally evaluate the economic and non-economic factors that explain any apparent associations, and how these associations differ for subgroups of older adults, including by their own level of educational attainment and features of their country’s social policies.